Mechanisms for control of mitoribosome assembly by the GTPase ERAL1

Abstract
Mitochondria assemble their own ribosomes in order to translate the membrane-bound components of the
electron transport chain. To do this, ribosomal RNA processing and folding and its sequential assembly with
more than eighty protein subunits must be finely coordinated. Impairments of mitoribosome assembly through
mutation of ribosomal subunits, assembly factors, or mitochondrial ribosomal RNA processing cause diverse
mitochondriopathies. The GTPase ERAL1 is conserved as an essential RNA-binding GTPase functioning in
assembly of the ribosomal small subunit between E. coli (Era) and human mitochondria. Deletion of ERAL1 is
lethal in mice and its mutation causes a form of Perrault syndrome, which is characterized by sensorineural
hearing loss and ovarian dysgenesis with variable neurological pathology. The molecular function(s) by which
ERAL1 contributes to ribosome assembly, however, have not been described. ERAL1 binds the small subunit
rRNA (the 12S RNA) until mid-assembly and is important for its stability, but what transformation of the 12S
RNA and small subnit ERAL1 conducts has not been defined. In addition, the mitochondrial AAA+ protease
CLPX-CLPP complex (CLPXP) appears to be important to remove ERAL1 from the assembling small subunit,
to either terminate the normal function of ERAL1 or to resolve an off-pathway intermediate. Loss of CLPXP
causes similar mitoribosomal dysfunction to loss of ERAL1 and mutations in CLPP also cause Perrault
syndrome. In preliminary studies, we have reconstituted direct degradation of ERAL1 by CLPXP and
discovered several factors that enhance or inhibit degradation, restricting degradation of ERAL1 to a particular
state. We also determined that a Perrault mutation in ERAL1 blocks regulation by one of these factors. The
goal of this proposal is to establish a molecular framework for the function and regulation of ERAL1 in
mitoribosome assembly. Through the strategies we propose in Aim 1, we will determine how CLPXP senses
the state of ERAL1 and how this is linked to mitoribosome assembly to terminate ERAL1-small subunit
association, using our biochemically reconstituted system to examine degradation complex assembly and
function. In Aim 2, we will define how ERAL1 GTPase activity and removal by CLPXP is coupled to maturation
of the 12S RNA, using cell culture-based analysis of 12S RNA processing. These studies will provide direct
molecular insight into a mechanism for disease in Perrault syndrome as well as identify potential targets for
treatment of the broader spectrum of mitochondrial disease resulting from impaired mitoribosome biogenesis.

Public health relevance
Project Narrative Mitochondria must assemble their own ribosomes to produce the membrane-bound components of the electron transport chain, which drives the synthesis of ATP; failures in mitoribosome assembly drive diverse mitochondrial diseases. ERAL1 is an assembly factor for the mitoribosome and mutations in ERAL1 or its regulator, the protease CLPP, drive two forms of Perrault syndrome. Our studies will reveal key steps in the control of mitoribosome assembly by ERAL1 and CLPP, thus revealing a molecular basis of Perrault syndrome and establishing potential targets for the treatment of a wider spectrum of mitochondrial disease.